LIPID SOLUBLE BETA-BLOCKER IN OBESE AND NON-OBESE HUMANS

Determine how the lipid solubility property of propranolol effects the pharmacokinetics and pharmacodynamic characteristics in obese compared to non-obese humans.